Predicting poor response to therapy and developing interventions to improve outcomes

PROJECT SUMMARY
Dr. Alexis Ogdie is a rheumatologist and epidemiologist who directs the Penn Psoriatic Arthritis (PsA) and
Spondyloarthritis Program at the University of Pennsylvania. She has established a robust, well-funded,
patient-oriented research program in which she mentors young investigators across a broad spectrum,
including junior faculty, postdoctoral fellows, rheumatology fellows, residents, medical students, and
undergraduates. The mission of her research program is to improve outcomes in PsA by accelerating
diagnosis, focusing on meaningful, patient-centered outcomes, and developing and advancing methods for
personalized medicine. Additionally, one of her primary long-term goals is to train the next generation of clinical
investigators in rheumatology and to support the pipeline of new rheumatology investigators nationwide, aiming
to improve outcomes for patients living with rheumatic diseases.
The proposed research in this K24 seeks to address potentially modifiable risk factors for poor response to
therapy—specifically obesity, depression, and anxiety—among patients with psoriatic arthritis. The proposal
will leverage an NIH-funded longitudinal cohort study to quantify the impact and interrelationships of these
factors on treatment response. The cost of these modifiable risk factors and poor treatment response will be
examined using administrative claims data. Finally, qualitative methods, informed by an implementation
science framework, will be employed to explore the barriers and facilitators to addressing these factors in
rheumatology clinical practice, incorporating the perspectives of patients and clinicians. This will inform the
development of an intervention aimed at mitigating these barriers.
In this application, Dr. Ogdie proposes to mentor early-career investigators in patient-oriented research
methods and expand her own research program by incorporating cost-effectiveness and implementation
science to enhance its impact, implementation, and dissemination. Penn offers an exceptional environment for
the proposed research and training, with abundant resources and co-mentors to support the trainees and the
work. She will recruit mentees from Penn Rheumatology, pediatric rheumatology at the Children's Hospital of
Philadelphia, the Epidemiology training programs, and several organizations with which she currently mentors.
This K24 is essential in providing protected time—free from administrative and clinical responsibilities—
allowing her to mentor trainees, expand her current work, and obtain further training to support her ongoing
development as a mentor, investigator, and leader.

Public health relevance
PROJECT NARRATIVE The goals of this K24 are to support Dr. Alexis Ogdie’s further development as a mentor and investigator and to allow her to expand the time she dedicates to the mentoring the next generation of patient-oriented researchers. This application will leverage available resources including an ongoing longitudinal cohort study, administrative data, access to a diverse patient population and an exceptional institutional environment. The proposed work will address the impact of obesity, depression and anxiety on outcomes in PsA and pave the way for novel studies that will change our approach to the care of patients with psoriatic disease in order to improve outcomes.